Core H: Down Syndrome Core

PROJECT SUMMARY - DOWN SYNDROME CORE (CORE H)
Since the inception of the UC Irvine Alzheimer Disease Research Center (ADRC) we have included people with
Down syndrome (DS) as a central focus of our research mission. In 2020, the ADRC established a dedicated
Core to support this research. Because of the triplication of the APP gene on chromosome 21, people with DS
accumulate amyloid in the brain over the lifespan, placing them at substantially increased risk for dementia. As
the largest population of genetic Alzheimer disease (AD), research in this group can provide insights into the
earliest events associated with AD pathogenesis. Yet, people with DS have been largely left out of AD/ADRD
research and excluded from AD clinical trials. Specifically, little is known about how race/ethnicity and social
determinants of health impact age of onset of dementia and later life changes in disease-associated outcomes.
In the next cycle, the DS Core will collaborate with other ADRC Cores to enhance diversity in our recruitment,
engage in recruitment science, and pilot novel outcomes for the DS Core. We will follow a longitudinal cohort
including 50 people with DS, aged 18 to 70 years, annually assessing clinical and cognitive outcomes as well as
biomarkers (neuroimaging and fluids), and inviting participation in brain donation. As an incubator for novel
hypotheses, the UCI ADRC DS Core can inform larger ongoing studies. Finally, we will continue to educate
investigators at UCI and beyond on the importance and methods of research in this key inadequately represented
population.